Noninvasive ultrasound vibro-elastography for assessing ocular disorders

PROJECT ABSTRACT
Our understanding of the role of ocular biomechanical properties, such as elasticity and viscosity, is incomplete
as there are no clinical methods for their in vivo clinical measurement. We propose to develop and refine a
novel noninvasive ultrasound vibro-elastography (USVE) technique to measure viscoelastic properties of
ocular tissues, and use the technique to assess two diseases, glaucoma and papilledema. We recently
completed a R21 grant, evaluating USVE for assessing glaucoma. Glaucoma is the second leading cause of
blindness in the US and worldwide, and the only available treatment is reduction of intraocular pressure (IOP).
Our pilot study found significant differences in wave speed in the posterior sclera between glaucomatous and
normal eyes. In another pilot project, we evaluated USVE in papilledema patients. Papilledema is optic nerve
swelling, caused by increased intracranial pressure, and can cause significant vision loss. Papilledema from
idiopathic intracranial hypertension (IIH) is typically bilateral and symmetric but can sometimes be asymmetric
and even unilateral. We found that wave speeds in the posterior sclera of IIH patients were significantly higher
than healthy subjects. In addition, wave speeds in patients with unilateral papilledema were significantly higher
in affected eyes, compared with unaffected contralateral eyes. Both diseases depend on the biomechanics of
ocular tissues including the posterior sclera surrounding the optic nerve head. However, they are on opposite
ends of the spectrum where the deformation of the lamina cribrosa is back bowing in glaucoma and forward
bowing in papilledema. Studying both diseases will help us to better understand the role of ocular tissue
properties in disease risk and development, and the basic viscoelastic characteristics of the eye. In Aim 1, we
will develop and refine USVE for measuring ocular viscoelastic properties. We will study various wave models
in ocular tissues and develop advanced viscoelastic models to analyze ocular tissue’s elasticity and viscosity
based on the wave speed dispersion measurements. In Aim 2, we will develop and refine USVE for assessing
50 patients with normal tension glaucoma (NTG) – glaucoma occurring at normal intraocular pressure – and 50
healthy control subjects. Since ocular biomechanical properties will be related to IOP, recruitment of NTG
patients will allow comparison with IOP matched controls. In Aim 3, we will develop and refine USVE for
assessing patients with papilledema. We will enroll a large cohort of 50 patients with papilledema from IIH and
compare them with 50 age- and gender- matched healthy control subjects. We will study the changes of USVE
measurements at baseline and after resolution of papilledema after treatment. Successful accomplishment of
this project will provide fundamental knowledge about the role of ocular tissue biomechanical properties in
glaucoma and papilledema. USVE may have the ability to stratify the risk of glaucomatous damage and the
propensity toward the development of papilledema and vision loss, and identify novel targets for therapy.

Public health relevance
PROJECT NARRATIVE Glaucoma is the second leading cause of blindness in the US and worldwide, and the only available treatment is reduction of intraocular pressure. Papilledema is optic nerve swelling caused by increased intracranial pressure, which has the potential to cause significant vision loss. Based on our promising pilot studies, we will develop and refine USVE for assessing glaucoma and papilledema as they are both dependent on the biomechanics of ocular tissues, including the posterior sclera surrounding the optic nerve head and USVE may have the ability to stratify the risk of glaucomatous damage and the propensity toward the development of papilledema and vision loss.